RNA data development of cancer cell lines and patients

This project is particularly informative in the area of transcript expression, including gene and in some cases isoform levels for some 1,600 cell lines and 186 patients. The standardization and presentation of the data in the form of a web-application makes it accessible for non-bioinformatics people. The cell line work was done prior to the patient and thus is further developed. The patient data currently resides on an internal site. The database allows multiple forms of comparisons to phenotypic, molecular, or pharmacological patterns. Data is being provided to the user as response to queries or in toto. The cell line data is accessible through our CellMiner or CellMinerCDB web-based applications. The project is meant to facilitate additional scientific analysis, tool development, and manuscript publication.